Investigating the dynamics of Salmonella Typhi and bacteriophages in the environment and the human gut

Salmonella Typhi, the causative agent of typhoid fever, is a neglected tropical disease that
spreads through contaminated food and water. Recent environmental surveillance studies from
Bangladesh and Nepal have found that prevalence of Typhi-specific bacteriophages in
wastewater correlated with the burden of typhoid fever in the community. Preliminary studies
from our group have uncovered that different genotypes of Salmonella Typhi have differing
phage susceptibility. Three of the most commonly circulating genotypes in Bangladesh (4.3.1.1,
3.3.2 and 4.3.1.3. Bdq) exhibit high phage resistance, suggesting a link between phage
resistance and the fitness and spread of Salmonella Typhi. Genomic analysis identified that
4.3.1.3. Bdq possesses the BREX anti-phage defense system, but no known phage defense
systems could be identified in genotypes 4.3.1.1 and 3.3.2. In the proposed study, we want to
use genetic, molecular, and biochemical methods to dissect the interaction between
bacteriophages and different strains of Salmonella Typhi to a) identify the molecular factors
that dictate Salmonella Typhi and phage interactions, and b) investigate how these factors
change over time in both the bacteria and phages. We also propose a longitudinal observational
study to identify prevalence of Typhi-specific phages in the human gut and their correlation
with typhoid fever. Taken together, this study will shed light on the role phages play in dictating
the spread and evolution of an important, but often, neglected infectious disease.

Public health relevance
Public Health Relevance: Bacteriophages are viruses that infect bacteria, and in doing so, regulate their abundance, evolution, and virulence. In this project, we want to investigate bacteriophages that infect Salmonella Typhi, the causative agent of typhoid fever, and investigate their prevalence and genetic heterogeneity in a setting where typhoid is endemic. We will also use genetic and biochemical tools to dissect the molecular mechanisms of the ongoing arms race between different strains of the Salmonella Typhi and its circulating bacteriophages.